Charting the Development of Exploration in Adolescent Bulimia Nervosa: A Neurocomputational Approach

PROJECT SUMMARY/ABSTRACT
Bulimia nervosa (BN) is a common and devastating illness that often emerges in adolescence, a time of dynamic
neural maturation and cognitive development. Dieting and impulsivity are implicated in the onset and
maintenance of BN. Yet, the few existing first-line treatments for adolescent BN primarily target dieting and
produce suboptimal outcomes. Impulsivity is a complex, multi-faceted process, and the neural circuits subserving
each facet change with development. The precise facets involved in adolescent BN remain unknown, hampering
targeted interventions. Suboptimal exploration is a neurocognitive process that may underlie impulsivity and be
salient to understanding adolescent BN. The overarching aim of this K23 Mentored Patient-Oriented Career
Development Award is to test the hypothesis that adolescent BN is characterized by the altered development of
exploration strategies and associated neural circuitry using an accelerated longitudinal design. Cohorts of early
(aged 12-15), middle (aged 14-17), and late (aged 16-20) adolescent girls with BN and group-matched controls
will be recruited. Each cohort will enroll 40 participants (20 BN/20 controls, N = 120). Adolescents will complete
a bandit task that uses computational modeling to parse exploration strategies during fMRI scanning to decipher
the neural correlates of exploration strategies. At 1- and 2-year follow-ups, adolescents will remotely complete
the bandit task and clinical measures to examine developmental shifts in exploration strategies and their cross-
sectional and prospective associations with BN symptoms. This design will test the following hypotheses: 1)
adolescents with BN will not show shifts in exploration strategies over time, whereas controls will rely more on
directed exploration and less on value-free random exploration over time (Aim 1); and 2) adolescents with BN
will show altered neural activation and effective connectivity patterns during exploration that will be similar across
BN age cohorts, but neural patterns will differ across control age cohorts (Aim 2). Links between exploration
strategies and associated neural activation and effective connectivity and BN symptoms at baseline and over
time will be examined (Exploratory Aim). The research will serve as a platform for mentorship and hands-on
training in concepts and skills to support the candidate’s transition to independence. Specifically, the study will
provide training in neurodevelopmental methods (e.g., adolescent recruitment and retention, longitudinal
analysis, Training Aim 1) and computational modeling of brain and behavior data (Training Aim 2). The candidate
will receive conceptual training in translational, transdiagnostic reward processing models to help her develop
more precise models of adolescent BN (Training Aim 3). The research will support the candidate’s first R01 by
yielding preliminary data on the neuro-computational and -developmental bases of BN and generating insights
into developmentally sensitive clinical targets. Ultimately, the candidate’s research program will inform
mechanistic, age-appropriate interventions that promote lasting recovery from this pernicious illness.

Public health relevance
PROJECT NARRATIVE Bulimia nervosa (BN) often emerges in adolescence and is associated with excess morbidity and premature mortality, but first-line treatments for adolescent BN produce suboptimal outcomes. This study will apply computational modeling to brain and behavior data to test whether adolescent BN is characterized by altered development of exploration strategies and underlying neural circuits. Findings will generate insights into developmentally sensitive clinical targets for BN, paving the way for mechanistic, age-appropriate interventions that promote lasting recovery from this devastating illness.